STIMULATING ACCESS TO INFECTIOUS DISEASES RESEARCH IN RESIDENCY (UAB StARR)

PROJECT SUMMARY and ABSTRACT
Infectious diseases continue to have a major impact on global health. Clinician-investigators have an important
role in addressing infectious diseases through research whose findings can advance the development of new
diagnostic, treatment, and prevention strategies. However, there is a decreasing number of clinician-
investigators in infectious diseases to meet this need. Innovative training schemes to reinvigorate the next
generation of clinician-investigators to address infectious diseases concerns are needed. The University of
Alabama at Birmingham (UAB) is committed to training and retaining a pipeline of clinician-investigators and has
established a physician scientist development office (PSDO) that provides support and resources for this
pipeline. Residency is a pipeline stage with heavy clinical burden and there is a need for mentored research and
training opportunities during residency to help retain those with an interest in a clinician-investigator career. The
goal of the UAB StARR Program is to recruit, train, and accelerate the research independence of UAB resident-
investigators to help build the next generation of clinician-investigators addressing infectious diseases. The
program will achieve its goal through three specific aims: Aim 1 (Pre-StARR Phase): Identify, recruit, and
cultivate resident-investigators interested in infectious diseases who are diverse by gender, race, ethnicity, and
residency specialties – starting in post-graduate year 1, multiple strategies will be used to identify and recruit
resident-investigators for the UAB StARR program from a diverse resident pool within the UAB Internal Medicine,
Pediatrics, OB/GYN, Pathology, and General Surgery residency programs who have interest in infectious
diseases. Aim 2 (StARR Research Phase): Provide mentored research and career development activities for
resident-investigators to promote curiosity in and preparedness for a career involving infectious diseases
investigation - up to 4 residents who apply and are selected for UAB StARR each year will complete a 12-month
program that includes: 1) research mentored by one of 34 preceptors with an excellent mentoring track record
and funding in research on infectious diseases and/or immune mechanisms impacting them, and 2) career
development activities leading to core competencies in research methodology, responsible conduct of research,
communication of findings, scientific writing, and team science. Aim 3 (Post-StARR Phase): Maintain continued
mentorship and career development engagement to retain resident-investigators’ interest and preparedness for
a clinician-investigator pathway - after completing the 12-month StARR program, participants will have continued
mentored research opportunities (up to 12 months), career advising through regular meetings with StARR
leadership and preceptors, and participation in career development activities, research conferences, and a
monthly interactive StARR Cohort “Next Steps” series. The impact of UAB StARR will be the development of a
diverse group of highly motivated, well-trained, early clinician-investigators who are prepared for a successful
transition towards a career as an independent clinician-investigator with a research focus on infectious diseases.

Public health relevance
PROJECT NARRATIVE Infectious diseases continue to have a major impact on global health and clinician-investigators play an important role in addressing infectious diseases through research whose findings can advance the development of new diagnostic, treatment, and prevention strategies. The goal of the University of Alabama at Birmingham (UAB) StARR Program is to recruit, train, and accelerate the research independence of UAB resident-investigators through mentored research, training in research methodology, and career development activities. The impact of the program will be generation of a pool of diverse resident- investigators with the knowledge, skills, experience, unique perspectives, and motivation that are all necessary to facilitate transition towards becoming the next generation of highly successful clinician- investigators who combat the burden and challenges of infectious diseases.